Human Islet Research Enhancement Center for the Human Islet Research Network

ABSTRACT
The Human Islet Research Network (HIRN) was established to support innovative and
collaborative research into how human beta cells are lost in type 1 diabetes (T1D), and to find
pioneering strategies to protect and replace functional beta cell mass in humans. This Network
consists of five consortia, each with a distinct focus complementary in scope, actively working to
achieve this goal. The science brought to bear is multidisciplinary, technically challenging, and
requires intensive efforts in order to make innovative and translational breakthroughs in
preventing and curing T1D. To advance the work, this application establishes a Human Islet
Research Enhancement Center (HIREC) to provide the administrative leadership, a centralized
organizational infrastructure, an information technology platform, and a research dissemination
engine to address the burgeoning needs of the HIRN for the next five years. The HIREC will
replace and leverage the efforts and investments of the HIRN Coordinating and Bioinformatics
Centers, which investigators in this proposal established in 2014. The overall objective of the
HIREC is to cultivate and facilitate team science within HIRN. The following specific aims of this
application are proposed to provide Meetings, Opportunities, Resources, and Exchange
(MORE) to HIRN: 1) Provide research operations and organizational services to support
scientific meetings, annual retreats, workshops, committees, working groups, and panels, 2)
Facilitate and accelerate new research paths through funding opportunities and collaboration
with other T1D and related communities, 3) Enhance a modern technology platform to provide
and preserve access to HIRN materials, data, and other resources, using available or expanded
vocabularies, ontologies, identifiers, and data formats, and 4) Catalyze collaboration and
innovation in T1D research through the exchange of ideas, findings, and data generated in
HIRN. Delivering MORE to HIRN will facilitate the ultimate goal of creating permanent
preventive and curative therapies in T1D.

Public health relevance
PROJECT NARRATIVE The Human Islet Research Network (HIRN) brings together many of the world’s leading scientists and laboratories to address essential questions related to the loss of functional human beta cell mass in Type 1 Diabetes (T1D). The science brought to bear is multidisciplinary, technically challenging, and requires intensive efforts in order to make innovative and translational breakthroughs in preventing and curing T1D. To cultivate and facilitate this work, a Human Islet Research Enhancement Center (HIREC) will be established that integrates and builds upon the work of and lessons from the HIRN Coordinating and Bioinformatics Centers.